Impact of Online Ordering on Low-Income Adults’ Food Security in Online Food Pantry Settings

PROJECT SUMMARY
The Administrative Supplement to my Mentored Research Scientist Development Award (K01AG064146) will
provide additional support to my long-term career objective of becoming an independent investigator who
specializes in improving diet practices and preventing chronic disease development in high-need groups,
including those with food insecurity and older immigrant adults. Some choice-based food pantries in the U.S.
are transitioning to online ordering. This transition is significant because online ordering may increase the use
of food pantries overall and increase food security, potentially via increased self-efficacy and reductions in wait
times and stigmatization. In addition, potential improvements in food security may vary by age group, given key
differences in barriers to food pantry use among younger versus older food pantry clients. To our knowledge,
however, there have been no evaluations of the transition to online ordering in food pantries. Building on the
research and training goals of my K01 award, the specific aims of this Administrative Supplement are: 1)
Determine whether the transition to online ordering at a choice-based food pantry network in New York City
influences food security status among low-income adults using a natural experiment design; and 2) Determine
whether there are differences in outcomes by age group. We will accomplish these aims by recruiting 386 low-
income adults aged >18 years from Met Council's Kosher Food Network, including 193 clients who visit a food
pantry on the cusp of transitioning to their Digital Choice Food Pantry System and 193 clients who visit a client-
choice food pantry not transitioning to online ordering (controls). The findings from the proposed research will
support the development of a novel approach to improving food security and healthy food choice in a high-
need population, while still being within the scope and timeline of the Parent Grant. This supplement will also
build on the training plan of the Parent Grant, enabling me to enhance my understanding of: 1) aging and
health, 2) behavioral economics, 3) experimental research methods, and 4) survey design; and, uniquely, 5)
provide training in community-partnered research methods, which is important for the sustainability and
significance of my research agenda. The proposed supplemental aims will also support my transition to
scientific independence and, importantly, strengthen my future applications for competitive funding.

Public health relevance
PROJECT NARRATIVE The goal of the proposed research is to determine whether the transition to online ordering at a choice-based food pantry network influences food security status among low-income adults, and determining whether there are differences in impact by age group. The results will inform changes to food pantry network across the U.S. in an effort to improve food security and reduce disparities in chronic disease risk in population with low resources, including immigrant older adults.